TSE Prion Cell Biology

Transmissible spongiform encephalopathies (TSEs) are a group of neurodegenerative diseases affecting a wide variety of mammals including sheep and goats (scrapie), cervid spp. (chronic wasting disease), and humans (Creutzfeldt-Jakob disease). Our studies are focused on the prion protein (PrP) due to the critical role of this protein in controlling many aspects of TSE pathogenesis such as susceptibility to disease and interspecies transmission. A central event in TSE disease involves the conversion of the normal host cellular prion protein (PrPC) to a partially protease-resistant, aggregated, disease-associated isoform (PrPSc). TSE-induced pathology is usually associated with PrP-res deposition, but the mechanism of neurodegeneration is not understood. The nature of the infectious agent, called a prion, remains uncertain but is thought to be composed primarily of misfolded PrP, perhaps in complex with another host accessory molecule(s). PrPC is a glycosylphosphatidylinositol (GPI)-anchored glycoprotein, and the majority of PrPSc produced in vivo contains this GPI anchor. Membrane association of both normal and disease-associated PrP isoforms may influence many features of prion disease and PrPC function. Our work is focused on elucidating mechanisms of uptake, replication, and spread of prions, in addition to determining the biochemical composition of mammalian prions. In 2015, we have continued the characterization of novel synthetic strains of TSE agents that originate from purified recombinant PrP and further investigated mechanisms of uptake, propagation, and intercellular spread of PrPSc via imaging studies in novel culture systems using primary neurons. Experiments on synthetic TSE strains confirm we have isolated a unique synthetic TSE prion completely dependent on GPI-anchorless PrPC for propagation. We have also characterized strain-dependent changes to TSE agents that occur during propagation in hosts expressing GPI-anchorless PrPC.